Gene edited B cells to co-express CNS-targeted antibodies

ABSTRACT
The CNS is a viral reservoir in HIV-infected individuals, 50% of whom will eventually develop HIV-
associated neurodegeneration (HAND), despite antiretroviral drugs. Antibodies can also be powerful antivirals,
promoting virus neutralization and the removal of HIV-infected cells through mechanisms such as ADCC and
ADCP. Of special interest are broadly neutralizing antibodies (bnAbs), which can recognize the Env proteins
from diverse viral strains and are therefore somewhat resistant to viral escape. As such, bnAbs are considered
a promising approach for treating or preventing HIV infection, although the lack of induction of bnAbs by
vaccination means that they are currently only used as injected proteins, or expressed from gene therapy vectors
in non-immune tissues. An additional concern for CNS infections is that antibodies are present at lower rates in
the CNS than the blood, although this can be enhanced by the addition of brain penetrating modules to the
antibody.
We have developed a gene editing strategy that allows us to reprogram human B cells to express specific
antibodies. Our strategy takes advantage of the ability of B cells to respond to the presence of their cognate
antigen, resulting in long-term secretion of the engineered antibody. We will now adapt this strategy to allow the
co-expression of both bnAbs and modified brain-penetrating antibodies (BP-Ab) from the same edited cells.
Using a range of assays, we will evaluate whether BP-Abs expressed from edited B cells retain full anti-HIV
activities and show enhanced delivery to the CNS. In this way we will have developed the necessary proof of
concept that a B cell therapy could be developed to provide long-term, HIV-responsive expression of brain-
penetrating bnAbs.

Public health relevance
PROJECT NARRATIVE The brain contains HIV-infected cells that are challenging to access by the immune system, including antibodies. In this proposal we will combine antibodies with brain-penetrating properties with a gene editing strategy to create B cells capable of secreting such antibodies. In this way we hope to develop a B cell therapy that could provide long-term, HIV-responsive expression of brain-penetrating anti-HIV antibodies.